Molecular and Cell Biology Resources Core (MCBRC)

MCBRC Project Summary
MOLECULAR AND CELL BIOLOGY RESOURCES CORE (MCBRC)
Molecular and Cell Biology provide an essential linkage among important basic fields of biomedical sciences,
such as genetics, developmental biology, structural biology, immunology, neurobiology, and cancer biology.
Centralized core facilities offering specialized equipment and services in molecular and cell biology,
immunology, immunopathology, and microscopy are often called on to provide critical support for biomedical
research. The Molecular and Cell Biology Resources Core (MCBRC) will provide, development, and training
functions based on the variety of needs for advanced molecular/cell biology support by Louisiana Biomedical
Research Network (LBRN) junior investigators. The main goals of the MCBRC are to: 1) Provide access to the
sophisticated equipment and expertise of the biomedical research intensive (BRI) institutions throughout
Louisiana, with the LSU flagship campus in Baton Rouge being the primary site (LSU School of Veterinary
Medicine, LSU College of Science, Pennington Biomedical Research Center) 2) Train and support all LRBN
investigators by helping them develop or adapt technological assays and methodologies needed for their
projects. Access to expensive equipment and experienced technical support is facilitated through a four-prong
strategy: i) PUI faculty and staff are invited to spend typically 2-3 days in the main MCBRC facilities to receive
hands-on training, as well as advice about their research projects; ii) training through organized workshops and
teleconference sessions, as well as “Works in Progress” sessions; iii) providing specific services and reagents
via the internet communication and order managing tool iLab; iv) provide on-site support and consultations
for PUI campuses through scheduled visits of MCBRC leadership and technical staff; v) provide “Core
Bucks” funds for all PUI investigators regardless whether they are funded by the LBRN. MCBRC leverages
the resources and expertise of three existing core facilities operated by the Division of Biotechnology and
Molecular Medicine (BioMMED) at the LSU School of Veterinary Medicine (SVM): Gene expression and
sequencing laboratory (GeneLab); Protein Production, Purification, and Characterization Laboratory (PPPCL),
and the molecular immunopathology laboratory (MIPL). These three laboratories are co-supported by the
NIH:NIGMS COBRE Center for Experimental Infectious diseases and the new COBRE Center for Lung Biology
and Disease (CEIDR). The specific aims of the MCBRC are:
Specific Aim I: To support the research efforts and activities of all LBRN investigators by providing
advanced molecular cell biology, microscopy, immunology, and pathology services, and access to
state-of-the-art equipment, expertise, and resources.
Specific Aim II: To organize, coordinate and facilitate interactions among LBRN investigators, mentors
and students; promote the development and use of new technologies and assays; and train PUI
faculty, staff, and students in advanced molecular and cellular biology technologies.

Public health relevance
MCBRC Project Narrative MOLECULAR AND CELL BIOLOGY RESOURCES CORE (MCBRC) The Molecular and Cell Biology Resources Core (MCBRC) will provide, development and training functions based on the variety of needs for advanced molecular/cell biology support by Louisiana Biomedical Research Network (LBRN) junior investigators. The main goals of the MCBRC are to: 1) Provide access to the sophisticated equipment and expertise of the biomedical research intensive (BRI) institutions throughout Louisiana, with the LSU flagship campus in Baton Rouge being the primary site (LSU School of Veterinary Medicine, LSU College of Science, Pennington Biomedical Research Center) 2) Train and support all LRBN investigators by helping them develop or adapt technological assays and methodologies needed for their projects.